The role of Piezo1 in bone homeostasis and mechanotransduction

PROJECT SUMMARY/ABSTRACT
Mechanical stimuli promote bone growth and are critical for skeletal homeostasis during adulthood. Loss of
mechanical signals decreases bone mass and increases fracture risk. Osteocytes, which are cells buried in the
bone matrix and derived from osteoblasts, are able to sense changes in mechanical load and orchestrate bone
remodeling. Several lines of evidence suggest that calcium channels are involved in the sensing of mechanical
load by osteocytes. For example, calcium influx is one of the earliest responses of osteocytes to mechanical
stimuli in vitro and in vivo. Consistent with a functional role for calcium signaling in the response to mechanical
forces, the response of osteocytes to mechanical stimuli can be inhibited by blocking calcium channels using
chemical blockers. Moreover, load-induced bone formation in the rat ulna is significantly blunted by calcium
channel inhibitors. However, the identity of the calcium channels activated by mechanical forces and their
functional role as mechanosensors in bone remain unclear. We have found that Piezo1 calcium channel is
highly expressed in osteocytes, and that its expression and activity are increased by mechanical stimulation in
osteocytes. In addition, deletion of Piezo1 in osteoblasts and osteocytes decreases both bone mass and bone
strength in mice, consistent with loss of skeletal responsiveness to mechanical stimulation. Moreover, the
skeletal response to anabolic loading is blunted in mice lacking Piezo1 in osteoblasts and osteocytes. Wnt1, a
ligand for Wnt signaling that is known to be upregulated by mechanical signals and stimulate bone formation, is
downregulated in Piezo1 conditional knockout mice. Importantly, activation of Piezo1 by its chemical agonist,
Yoda1, mimics the effects of fluid flow on osteocytes and increases bone mass in mice. Based on this
evidence, we hypothesize that osteocytes sense changes in mechanical signals through Piezo1 and thereby
promote bone formation in part by activating signaling pathways that increase the expression of Wnt1. To test
this hypothesis, we will determine whether Piezo1 expression by osteocytes is required for mechanical sensing
in the murine skeleton. We will generate mice in which Piezo1 is deleted from osteocytes, but not osteoblasts,
and compare their skeletal phenotype to that observed in mice lacking Piezo1 in osteoblasts and osteocytes.
We also will delete Piezo1 postnatally in adult mice and investigate their response to mechanical loads by tibia
compression (Aim 1). In addition, to understand how Piezo1 promotes bone formation, we will determine the
role of Wnt1 in Piezo1-mediated bone formation in vivo using a mouse genetic approach (Aim 2). In Aim 3, we
will determine whether Piezo1 is responsible for the skeletal response to unloading using a tail-suspension
model. Lastly, we will determine whether pharmacological activation of Piezo1 prevents bone loss associated
with unloading or increases bone mass in old mice. Successful completion of this work should establish a new
model for understanding the skeletal response to anabolic mechanical loading and may suggest new strategies
to develop anabolic therapies for bone loss related to disuse or aging.

Public health relevance
PROJECT NARRATIVE Mechanical signals promote osteoblast differentiation and bone formation, but the molecular mechanisms remain unclear. The aim of proposed studies is to uncover the underlying mechanisms and this will be accomplished by studying a mechanosensitive ion channel Piezo1 and its downstream effectors in osteocytes. The successful completion of this work may provide new strategies to modulate regenerative responses and develop therapies to treat the bone loss related to disuse or advanced age.